Catalytic C-C Bond Forming Hydrogenations

Project Summary: As exemplified by the Haber-Bosch reaction, which sustains half the human population, and enantioselective hydrogenation, which is the foremost chemical method used to create chiral pharmaceutical and agrochemical ingredients, catalytic hydrogenation has had a greater impact on how humans live and die than any other chemical process. Prior to our work, the sole example of a “C-C bond forming hydrogenation” was hydroformylation, which is the largest application of homogenous metal catalysis. My laboratory has pioneered a broad, new class of C-C bond formations that merge the characteristics of catalytic hydrogenation and carbonyl addition ? processes in which two or more reactants are hydrogenated to form a single, more complex product. These transformations bypass the use of stoichiometric carbanions, offering a byproduct-free alternative to a range of classical carbonyl or imine additions. This concept is extended further by “C-C bond forming transfer hydrogenations” that directly convert lower alcohols to higher alcohols, again in the absence of stoichiometric metals. In the proposed funding period, we will develop methods for the stereo- and site-selective formation of quaternary centers, the use of α-olefins as couplings partners, and the use of base metal (Fe, Co) catalysts. Our goal is to develop environmentally benign methods for the conversion of inexpensive chemical feedstocks to value-added building blocks for use in the manufacture of pharmaceutical and agrochemical ingredients.

Public health relevance
Project Narrative: C-C Bond formation is central to the endeavor of chemical synthesis. We have developed two new classes C-C bond formations: (a) reductive couplings induced via catalytic hydrogenation, and (b) H2-auto-transfer processes that directly convert lower alcohols to higher alcohols. Here, we propose to continue our investigations into the direct redox- triggered C-C coupling of alcohols with a focus on the development of stereo- and site-selective methods for construction of quaternary centers, the use of α-olefins as couplings partners, and the use of base metal (Fe, Co) catalysts.